Support of the Research Effort to Evaluate the Cardiotoxic Potential of Multiple Test Agents in Rats

This project conducted for the Division of Translational Toxicology (DTT) is designed to develop and qualify a toxicity evaluation pipeline for test agents with cardiotoxic potential. A suite of 9-10 chemicals were selected based on demonstrating the ability to be cardiotoxic from published literature of mechanistic, in vitro or in vivo studies. These chemicals are being tested in a 14-day repeat oral gavage study in rats with an emphasis on evaluation of the heart using histopathology and transcriptomics, as well as internal dose monitoring to provide translational data for animal to human and in vitro to in vivo extrapolation.